"Investigating the rebound effects of seasonal malaria chemoprevention (SMC) in Mali"

Summary
Seasonal Malaria Chemoprevention (SMC) has been recommended by WHO for malaria endemic countries in
sub-Saharan Africa with strong seasonal malaria transmission since 2012. The intervention consists of the
administration of full treatment doses of Sulfadoxine-Pyrimethamine (SP) plus Amodiaquine to children less than
5 years of age every 4 weeks during the malaria transmission season for 3 to 4 rounds per year. Since 2016,
Mali has implemented the strategy countrywide. While significant decreases in malaria cases among the target
age group was observed, increasing trends in malaria among children 5 years and above is also reported in the
many settings where SMC is being implemented. The proposed study considers previous studies and pilot data
showing that approximately out of every eight children (12.5%) have historically received either no doses or a
single dose out of a the required four doses for the treatment regimen. This study seeks to enroll a large cohort
of children to permit a large-scale comparison between children previously compliant to SMC with a valid control
group (children not previously compliant to SMC) to elucidate the effects of phasing out of the SMC program due
to age ineligibility. The primary objective of this R01 proposal is to investigate the withdrawal effects of SMC
due to age eligibility requirements through the following three specific aims: 1) Determine malaria rebound
occurrence following SMC enrollment including its association with severe malaria and anemia; 2) Assess
changes in the age-specific P. falciparum prevalence, sexual and asexual parasites, and multiplicity of infection
following SMC deployment; and 3) Assess the change in immune response to malaria antigens during and
following SMC eligibility and the relationship with disease. The study will provide valuable information on the
impact of SMC stoppage at five years of age which can significant contribute improving monitoring malaria
outcomes in other low- and middle-income countries overall.

Public health relevance
Seasonal malaria chemoprevention (SMC) is a prophylactic antimalarial regimen of sulfadoxine- pyrimethamine (SP) and amodiaquine (AQ) recommended by the World Health Organization (WHO) for preventing malaria episodes in children under 5 years of age in highly seasonal transmission settings. The purpose of the proposed study is to assess for potential long-term impact of SMC on malaria severity and immune response among children after they quit SMC program through a longitudinal cohort study. The study will provide data on the effectiveness of SMC in relation with compliance and valuable information on the burden of malaria when children are no longer in the program. It will also contribute to understanding the underlying biological basis of potential rebound of severe malaria and anemia after SMC and evidence basis for pursuing SMC strategy beyond current target age.